FOLATE SUPPLEMENTATION IN INDIVIDUALS WITH COLONIC ADENOMAS

Epidemiologic work performed by others, as well as animal studies performed by our laboratory, indicates that enhanced folate status decreases the progression of colonic carcinogenesis in individuals who are pre-disposed to colon cancer. This is a prospective, placebo- controlled trial to examine whether folate supple mentation reduces certain intermediary markers of colonic neoplasia (ie: proliferative index of rectal mucosa, DNA methylaiton of rectal mucosa, c-myc oncogene expression) in such individuals.